Active_Case_Finding_Testing_and_Linkage_to_Treatment_and_Improved_Survival_(ACTTIS)_Study

Abstract Active Case Finding (ACF), used to identify people with TB disease, not presenting for their own symptoms, is recommended, but rarely performed outside health faculties in high disease burden settings. Contacts of a TB case are a key population at extreme risk of both prevalent and incident TB and likely should be included in ACF strategies. However there is little evidence to support this. Moreover, there is no data describing efficacy of contact tracing where the index case is a young child with TB, both because of great challenges in diagnosing pediatric TB and because young children are considered epidemiologic “dead-ends”. Our pilot study of contact tracing in hospitalized, children with TB, found high rates of previously undiagnosed HIV and TB. Using sentinel children with TB, we plan to assess the impact of a home-based ACF, HIV and TB testing, home-initiation of therapy, with linkage to treatment on improving HIV and TB free survival in the household. Hospitalized children (?5 years) diagnosed with TB will be allocated to either our intervention – a combination of several already proven strategies - or the standard of care plus arm. Our intervention will, at baseline screen caregivers and other household contacts for HIV, and TB disease and infection, and initiate appropriate treatment in the household, and thereafter link individuals to care and treatment at local health facilities. The current standard of care is to test the child with TB for HIV and then passively refer for ART initiation if HIV-infected. Little or nothing is currently done for close contacts of the index child with TB. However, for all TB-positive children randomized to the non-intervention arm, we will test the mother/caregiver at the hospital for both HIV and TB, then conduct a baseline household assessment with referral for care as appropriate. Outcomes will be measured in all households, at final 27 month follow-up household visit to test all contacts for HIV and TB. We hypothesize that our home-based intervention will significantly improve TB- and HIV-free survival in the entire household because of early and improved rates of initiation, and adherence to HIV and TB treatment, and TB preventive treatment3-5. We will also measure and compare viral loads in all HIV-infected household members at the end of follow up. TB commonly co-exists with severe lower respiratory tract infections (LRTI),6 but about 47% of hospitalised children with culture-confirmed TB are not diagnosed with TB whilst in hospital. Moreover, there is an absence of data describing the TB and HIV burden in the household contacts of children with LRTI. Thus it is critically important to evaluate whether targeting children with TB cases - a minority of admissions - or, including those with LRTI – the majority of pediatric admissions - is worthwhile. We will therefore also assess prevalence and incidence of TB and HIV in household contacts of children admitted to hospital with LRTI. Incremental cost effectiveness will be calculated to compare the yield of undiagnosed or untreated HIV and TB infection at baseline; and overall survival, without incident HIV infection and/or TB disease.

Public health relevance
PROJECT NARRATIVE TB and HIV are leading causes of death and illness in South Africa where large numbers of people do not know that they have HIV, or may delay before being diagnosed with TB. Parents are more likely to immediately bring young children to a clinic or hospital when they develop illness, compared to adults who may delay some time before seeking medical help for their own illness. Moreover, TB in young children suggests that an infectious person in the house “gave” TB to the child. This provides an opportunity for screening other household members for TB and HIV, and link them to care. However, it is not known if this strategy results in better household health or if it is cost effective. We will include children admitted to hospital with TB and then randomly allocate their households (like flipping a coin) to either: the Active Case finding, Testing for TB and HIV, with intensively supported Linkage to Treatment and Improved Survival (ACTTIS) group; or to receive household checks with simple referral letters for those with illness. All households will be followed up for two years. We want to see if more people survive without TB or HIV in households who received the intensive intervention and check the costs of doing ACTTIS. Also because it might be good to also do ACTTIS for other sick children, we will also check and follow up households of children who have chest infections that are not TB.